Paul B. Beeson Emerging Leaders Career Development Awards in Aging Annual Meeting

Project Summary/Abstract
The objective of the Beeson Program is to help develop a cadre of talented scientists prepared
to take an active leadership role in transformative change that will lead to improved research or
healthcare outcomes.The Beeson Annual Meetings (BAM) play an important role in nurturing
the career development and leadership of the Beeson Scholars. Funding of this competitive
renewal R13 application will allow us to build on the earlier meetings. We will leverage private
funding from the American Federation for Aging Research to support meeting expenses not
covered by the R13. We also plan to leverage the annual meeting organized by the Clin-STAR
Coordinating Center – a national platform that organizes activities and provides resources for
the cultivation, connection, and synergy of clinician-scientists in aging research from disparate
specialties across the US. The Clin-STAR meeting is scheduled immediately prior to the BAM
with one overlapping day, providing greater opportunities for networking and mentoring among
scholars in the two programs, with the more senior Beeson Scholars serving as role models and
mentors to the more junior Clin-STAR meeting participants This competing renewal R13
conference grant will allow current and former Beeson Scholars to: 1) foster collaboration with
other Scholars; 2) nurture and develop a collective identity; 3) support career development and
promote leadership skills that help Scholars become independent investigators and leaders in
geriatrics and aging research; 4) better exchange research information and network more
effectively; 5) provide access to colleagues from different disciplines who are working on similar
scientific issues related to aging; 6) receive mentorship from nationally recognized academic
leaders who can guide the Scholars’ research and career development; 7) develop mentoring
skills by providing mentorship to more junior investigators attending the Clin-STAR annual
meeting and 8) provide access to organizations, programs, and colleagues that can foster the
Scholars’ growth and development. During the next funding cycle, we are committed to
incorporating additional innovations to advance the mission of the program. For example, we
plan to incorporate a cross-disciplinary mini-theme into each Annual Meeting and to further
leverage the Clin-STAR Coordinating Center resources with targeted outreach to the Beeson
Scholars. We also plan to organize activities throughout the year such as office hours with the
Program Advisory Committee, virtual networking sessions, and structured mentoring between
Beeson Scholars and GEMSSTAR Scholars.

Public health relevance
Project Narrative The Beeson Program supports talented scientists in aging research prepared to take an active leadership role in transformative change that will lead to improved research or healthcare outcomes. The proposed series of annual meetings support the major goals of the Beeson program, which are to support career development, advance leadership skills and linking (external) mentors to the Beeson Scholars. The annual meetings encourage and support these goals, while at the same time facilitating the development of a collective identity and cohesiveness among the Scholars